CCR Education and Outreach

This project is important because it provides the public, congress, and scientific commiunities with an understanding of the research advances that are being made with American tax dollars. The publication and dissemination of research results is a critical component of what the CCR Office of Communications does. Education and outreach are key components to our ability to achieve our mission. Accomplishments this year include: Production of CCR Connections news magazine (in print and on line) to inform the public and research community about CCR's research advances. Dozens of summaries of important peer-reviewed journal papers written for the lay public and other activities are shared via the website: https://ccr.cancer.gov/news. The office works with NCI's Office of Communications and Public Liaison to disseminate press releases and to inform the media about the research progress being made within CCR. CCR launched a twitter account and also disseminates information to the public through NCI social media including LinkedIn, Instagram and Facebook. OC also works collaboratively with many other NCI and NIH organizations, including the Division of Cancer Treatment and Diagnosis; Division of Cancer Epidemiology and Genetics; Office of Congressional and Government Relations; NCI at Frederick; NCI Office of Advocacy Relations; the NIH Office of Intramural Research; and the NIH Clinical Center. The office supported multiple visits by interested Congressional staff, advocates, scientific collaborators and dignitaries. Provided articles for the NIH Record and the NIH Catalyst. Reviewed articles for NIH/NCI publications and the NCI at Frederick's The Poster. Provided writing and editing support to CCR staff.